Targeting central regulation of oncogenic signaling through inhibition of translation initiation complex eIF4F

Cancer is a widespread group of diseases with deleterious effects on society with regard to human health and
financial burden. Furthermore, the development of chemoresistance to first-line therapies is responsible for the
majority of deaths (over 90%) in tumor patients. Elevated protein synthesis is a critical trait that is associated
with genesis, poor prognosis, and drug resistance in many types of human cancers. Eukaryotic initiation factor
4F (eIF4F), a cap-dependent mRNA translation initiation complex forms a central node for frequently upregulated
oncogenic pathways such as Myc, Ras, and PI3K-AKT-mTOR. An essential requirement for the assembly and
operation of the eIF4F translational machinery is the interaction between subunits eIF4E and eIF4G. Inhibition
of this protein-protein interaction (PPI) has been recently demonstrated as a viable approach to target translation
initiation. However, the published PPI inhibitors suffer from low affinity and solubility issues along with off-target
effects. Thus, our goal is to develop novel drug-like and selective small molecule inhibitors of eIF4E/eIF4G
interaction. Our hypothesis is that the canonical motif-binding site on the surface of eIF4E can be targeted via
mimicry of eIF4G. Our computational approach identified novel scaffolds that could potentially inhibit this
interaction by targeting the hot-spot residues on the surface of eIF4E. These compounds are devoid of PAINS
characteristics and facilitate scanning of 3D space on the eIF4E surface. To test our hypothesis, we will pursue
three specific aims. Aim 1 will focus on the design and synthesis of novel PPI inhibitors with drug-like properties.
These synthesized compounds will be assessed in fluorescence polarization and pull-down assays to determine
the eIF4E/eIF4G interaction inhibition profile in Aim 2. Aim 3 will evaluate the cellular effects by testing the high-
affinity compounds in a dual luciferase assay. This assay enables the determination of inhibition of cap-
dependent versus cap-independent translation. Further, the selected compounds will be tested for their anti-
proliferative effects on human cancer cell lines.

Public health relevance
According to American Cancer Society, over 1.9 million new cases with approximately 609,360 deaths are expected from cancer in the United States in 2022. Besides, chronic drug treatment may result in development of resistance to the first-line anti-cancer therapies. Our approach to discover newer therapeutics is via targeting the mRNA translation initiation complex, eIF4F that is in feed-forward loop relationship with the oncogenic signaling pathways involved in metastasis and drug resistance.